Administrative Core

The Administrative Core (AC) of the Louisiana Biomedical Research Network (LBRN) oversees the coordination of various programs, including the Developmental Research Project Program (DRPP). Its responsibilities include managing cores (MCBRC and DSBC2), selecting research projects, evaluating progress, and organizing discussions on program policies. The AC is comprised of key personnel including the Program Director/Principal Investigator (PD/PI), Program Coordinator (PC), Program Manager (PM). Additionally, there are committees like the Steering Committee (SC) and Executive Committee (EC) and External Advisory Committee (EAC) involving representatives from primarily undergraduate institutions (PUIs) to provide direction and support for LBRN and a dedicated mentoring chair that oversees all mentors. Evaluation of LBRN activities is conducted through surveys and discussions with various committees by an internal evaluation committee (LSU SREC). The AC has specific aims to provide leadership, manage research projects and programs, and organize activities for research, career development, and curriculum enhancement. Overall, LBRN plays a crucial role in advancing biomedical research in Louisiana.

Public health relevance
The LBRN serves a crucial role in advancing biomedical research in Louisiana by providing funding, training, and extensive support to ten PUIs. Its impact extends beyond scientific discoveries to include education especially in data science and bioinformatics, biomedical research training, and workforce development. Our organizational plan will enable us to fully realize LBRN goals of advancing biomedical research. With highly skilled leadership and strong programmatic coordination securely in place, we are poised to undertake a new project period to enhance what we have already started and further impact the biomedical research landscape of our state.